Early life exposure to agricultural pesticides and functional brain imaging in young adults

ABSTRACT
Organophosphate (OP) pesticides are widely used insecticides. Since 1999, our Center for the Health
Assessment of Mothers and Children of Salinas (CHAMACOS) study has been assessing the health effects of
OP pesticides among a birth cohort of ~600 Mexican American youth in California’s agricultural Salinas Valley.
We have reported associations of prenatal OP pesticide exposure with poorer cognitive function and behavioral
problems from early childhood through adolescence. Further investigation using neuroimaging is important for
elucidating: 1) which structures and functions in the brain are adversely affected by OPs; and, 2) OP-related
impacts on brain function that may be undetected in studies using standard neurobehavioral tests. Only two
neuroimaging studies report associations with of early life OP pesticide exposure. The first includes a cohort of
40 New York City children, which found associations of prenatal exposure to the OP chlorpyrifos with reduced
cortical thickness of frontal, temporal, and parietal regions shown by structural magnetic resonance imaging
(MRI). In a subset of 95 CHAMACOS participants we found that residential proximity to OP use during pregnancy
was associated with altered brain activation patterns observed with functional near infrared spectroscopy (fNIRS)
during tasks of executive function. These preliminary findings warrant corroboration among a larger sample with
high quality exposure assessment during critical windows of brain development. In this project, we propose to
investigate associations of early life exposure to OP pesticides on neural activation patterns and functional
connectivity among the entire CHAMACOS cohort of young adults (18-19 years old).We have collected
neuroimaging data using functional near-infrared spectroscopy (fNIRS) – an alternative to fMRI with distinct cost
and convenience advantages for field-based research – in 458 participants of the CHAMACOS cohort. We
assessed neural activity in the prefrontal, temporal and parietal brain regions as participants complete tasks of
cognitive flexibility, working memory, and language comprehension. For ~300 CHAMACOS participants, we
have already analyzed dialkyl phosphates (DAPs), non-specific OP biomarkers, in maternal prenatal and early
childhood (6 months – 5 years) urinary samples. For all 458 participants, we have estimated exposure to
individual OP pesticides and their mixtures based on residential proximity to agricultural OP pesticide
applications using California’s unique Pesticide Use Reporting (PUR) database. Urinary DAPs and PUR data
provide complementary exposure measures, allowing for a more comprehensive examination of the effects of
OP pesticides from different sources during critical periods of development. For this project, we propose to
conduct the intensive processing of these multi-dimensional data and investigate associations of early life OP
pesticides exposure with cortical neural activation and functional connectivity using fNIRS. Our proposed
research will be the largest to assess impacts of pesticide exposure using functional neuroimaging, and the first
to apply fNIRS technology to localize impairments in neurodevelopment related to an environmental exposure.

Public health relevance
PROJECT NARRATIVE Organophosphate (OP) pesticides are widely used in the U.S. and worldwide. We have shown that early life exposure to OP pesticides is associated with poorer cognitive function and behavioral problems from early childhood through adolescence in our Center for the Health Assessment of Mothers and Children of Salinas (CHAMACOS) birth cohort study, drawn from a population living in close proximity to agriculture. In the proposed project, we will use a neuroimaging technology – functional near-infrared spectroscopy (fNIRS) – to determine how brain activity and connectivity is related to early life exposure to OP pesticides among 458 CHAMACOS youth age 18-19 years.